Chronic Stress, Inflammation, and Resilience: Predictors of Social Integration in Recently Housed Black and White Veterans

Despite the VA’s considerable success in reducing the number of homeless Veterans through permanent
supportive housing, a fundamental problem remains. Permanent housing is necessary, but not sufficient, for
successful social integration. Many Veterans remain isolated and without adequate social support after being
housed. Black Veterans disproportionately experience homelessness yet remain understudied in psychological
science. A better understanding of racial differences in risk and protective factors of social integration in
recently housed Black and White Veterans could inform the development of novel rehabilitative interventions.
This Career Development Award (CDA-2) proposes to utilize an innovative, multimodal approach to examine
the contributions of stress, inflammation, and resilience to social integration in recently housed Black and
White Veterans. Homelessness is extremely stressful and Black Veterans may experience additional stressors
due to systemic inequities that could impede social integration. Furthermore, psychosocial stress is associated
with an inflammatory response in the body. Inflammation could, in turn, exacerbate problems with social
integration given the increasing evidence of its effect on social behavior. However, previous work finds better
social integration in homeless Black Veterans compared to White Veterans, suggesting the presence of
protective factors that mitigate the effects of stressors on social integration in Black Veterans. Resilience is a
modifiable trait that might help buffer the negative consequences of stress and inflammation on social
integration. The extent to which these factors differentially impact social integration in recently housed Black
and White Veterans is relatively unknown. The overall goal of this longitudinal study is to examine racial
differences in the effects of stress, inflammation, and resilience on social integration in recently housed Black
and White Veterans. First, we will examine the cross-sectional and longitudinal associations of stress,
inflammation, and resilience with social integration. Second, we will examine whether race moderates these
associations. As an exploratory aim, we will examine an integrative longitudinal model of social integration,
including the risk and protective factors listed above and psychiatric symptoms, in recently housed Black and
White Veterans. Findings from this study have the potential to advance our understanding of risk and
protective mechanisms of social integration in recently housed Black and White Veterans and inform innovative
rehabilitative treatments that mitigate the effects of stress and inflammation to improve social integration.
This CDA will provide the applicant, Derek M. Novacek, PhD, with the training in the areas of: (1) social
integration and Veteran homelessness; (2) stress and inflammation, including multiple methods to assess
inflammatory markers; and (3) racial health disparities in Veterans. The applicant’s career goal is to become a
VA research psychologist, working to improve social integration in homeless Veterans and develop culturally
congruent interventions. The training outlined in this CDA application will lay the groundwork for the applicant
to develop an independent research program within the VA focused on determinants of social integration in
homeless Veterans. The VA RR&D Center on Enhancing Community Integration for Homeless Veterans
(THRIVe), VISN 22 Mental Illness Research, Education, and Clinical Center (MIRECC) at the VA Greater Los
Angeles Healthcare System (GLA), and the University of California, Los Angeles (UCLA) provide an excellent
environment and infrastructure to complete the proposed study. The primary mentor will be Michael F. Green,
PhD, the Director of THRIVe, Director of the VISN 22 MIRECC Treatment Unit, and an established researcher
in Veteran homelessness. The applicant will also receive specialized training from an expert in research with
vulnerable Veterans (Lillian Gelberg, MD, MPH), a leading researcher in inflammation (Steven W. Cole, PhD),
and a renowned scholar in racial health disparities in Veterans (Donna L. Washington, MD, MPH). The
applicant will also receive statistical consultation from biostatistician, Catherine A. Sugar, Ph.D.

Public health relevance
The VA has had considerable success in reducing the number of homeless Veterans through permanent supportive housing programs. Permanent housing is necessary, however, but not sufficient for successful social integration. Poor social integration is associated with a variety of adverse mental and physical health outcomes. Notably, Black Veterans are overrepresented among homeless Veterans yet remain understudied in psychological science. A better understanding of potential racial differences in risk and protective mechanisms of social integration is crucial for the development of culturally responsive rehabilitative interventions for recently housed Veterans. The proposed study aims to examine the contributions of stress, inflammation, and resilience to social integration in recently housed Black and White Veterans. Knowledge gained can inform innovative race-conscious treatments that mitigate the effects of stress and enhance resilience to improve social integration in recently housed Veterans.